Mentored Patient-Oriented Research of Novel Mechanisms Linking Pain, Sleep-Wake Patterns, and Autonomic Activity in Rheumatic Diseases

PROJECT SUMMARY/ABSTRACT
This K24 application seeks to provide protected time for the applicant, Yvonne Lee, MD, MMSc, to mentor
trainees in patient-oriented research (POR) and grow her research program. Dr. Lee is the Solovy/Arthritis
Research Society Professor in the Division of Rheumatology at Northwestern University (NU) Feinberg School
of Medicine. She is also the Associate Director of the Rheumatology T32 and Associate Director of the
Methodology Core of the NU Core Center for Clinical Research (P30). Her research focuses on understanding
pain mechanisms in patients with arthritis. This area presents a large unmet need, as few investigators have
expertise in both rheumatology and the neurobiologic mechanisms underlying pain. If new investigators are not
trained, millions of patients will continue to suffer, despite costly immunosuppressive drugs and/or surgeries.
Dr. Lee is well-suited to act as a research mentor because she has an established history of mentoring and
leading innovative interdisciplinary POR projects. She is the PI of an R01-funded, multi-site project to study
pain in patients with rheumatoid arthritis (RA), and she has served as primary or secondary research mentor
for over 20 pre- and post-doctoral research trainees. Support from the K24 would provide Dr. Lee with
protected time to: 1) mentor early investigators across various fields (e.g., rheumatology, kinesiology, sleep
and circadian medicine, neuroscience, anesthesiology, behavioral sciences) in POR; 2) improve POR
mentoring skills through training and guidance from senior mentors; 3) expand into new scientific areas (sleep
and autonomic medicine, neuroimaging) through interdisciplinary collaborations; and 4) replenish support for
her research program through new NIH funding. Her research has established that abnormalities in central
nervous system (CNS) pain pathways are important contributors to the pathogenesis of chronic pain in arthritis.
Preliminary data also suggest that sleep disturbances and autonomic dysfunction play key roles in this
process. The current proposal builds upon this work and leverages the infrastructure of her funded R01, which
is recruiting patients with early RA to identify changes in pain pathways during the first 12 months after RA
onset. This K24 will add assessments of sleep-wake patterns and parasympathetic tone to the ongoing study,
with the objective of identifying associations between these measures, neuroimaging assessments of
underlying CNS regulatory pathways, and patient-reported pain. In addition to these new research avenues,
mentees will benefit from working on: 1) existing data from the original Central Pain in Rheumatoid Arthritis
(CPIRA) cohort; 2) ongoing data collection from the expansion of CPIRA to patients with early RA in CPIRA-2;
and 3) data from other datasets to which Dr. Lee has access through existing collaborations. Conduct of the
proposed research program will advance the field by identifying modifiable pathways involved in the
development and maintenance of chronic pain in patients with arthritis. Ultimately, this work will suggest
potential therapeutic approaches that Dr. Lee and her research team will test in future interventional studies.

Public health relevance
PROJECT NARRATIVE Musculoskeletal pain is the leading cause of disability in the world, and the number one reason patients with arthritis visit healthcare providers. The proposed research will provide quality data on the association between sleep-wake patterns, parasympathetic activity, central nervous system regulatory pathways, and pain in patients with early rheumatoid arthritis. The proposed research is relevant to the NIH’s mission because it will enable the applicant to continue and expand her patient-oriented research training program, thereby fostering the development, maintenance, and renewal of trained investigators, including, but not limited to, those with expertise in tackling the unmet need of treating and preventing chronic pain in patients with arthritis.